Clinical Trials Network New England Consortium Node: Admin Supplement CTN0131

We will conduct a randomized, pragmatic hybrid type 1 effectiveness/implementation multisite (approximately 6
sites) trial to determine whether office-based methadone with pharmacy administration and/or dispensing or
buprenorphine (BUP) results in greater treatment retention in approximately 600 patients with opioid use disorder
(OUD) not optimally benefiting from office-based BUP. As part of the trial, we will identify implementation barriers
and facilitators at the patient, provider and health-systems level for office-based methadone with pharmacy
administration and/or dispensing.

Public health relevance
In patients with OUD not optimally benefiting from office-based BUP, the primary objective is to evaluate the comparative effectiveness of office-based methadone versus office-based BUP on retention in medication for opioid use disorder (MOUD) treatment (as randomized) at 24 weeks post-randomization.